Dissecting Neurocognitive Components of Compulsivity Using Computational Modeling and EEG

PROJECT SUMMARY/ABSTRACT
Compulsivity is a transdiagnostic maladaptive behavior implicated in several psychiatric illnesses including
obsessive-compulsive disorder (OCD)—the prototypical compulsive disorder that affects ~1.5% of people
worldwide. OCD is highly disabling, and gold-standard treatments like exposure and response prevention
(EX/RP) will result in remission for fewer than 50% of patients. Greater mechanistic understanding of
compulsivity could improve clinical outcomes and lead to novel targets for treatments and early interventions.
Thus, the goal of this K23 Award is to promote Dr. Rapp’s development into an independent clinical scientist
who uses precision analytic methods to advance understanding of neurocognitive mechanisms underlying OCD
and related anxiety disorders and translates these findings into innovative diagnostics and treatments.
Specifically, Dr. Rapp’s training plan will capitalize on a multidisciplinary mentorship team and an outstanding
research environment to enable her to gain expertise in: 1) methods and frameworks for studying transdiagnostic
brain-behavior associations that can be applied to research on compulsivity, 2) theory-driven cognitive
computational modeling, 3) trial-by-trial EEG analysis, 4) repeated-measures study design and analysis, and 5)
career development toward research independence. The proposed research project will use theory-driven
computational modeling together with trial-by-trial analysis of EEG to examine the neurocognitive mechanisms
underlying compulsivity and will provide hands-on experience to foster these training goals. Prior theories of
compulsivity purport that it is attributable to an imbalance between goal-directed and habitual behaviors, which
are putatively underpinned by the “model-based” (MB) and “model-free” (MF) cognitive systems. Research in
healthy individuals using computational modeling together with EEG has challenged this binary “dual-systems”
theory, revealing more complex interactions of neurocognitive subcomponents. Particularly, these studies have
shown that neurocognitive processes that support MB planning are combined with MF learning signals to
influence reward prediction errors, which are used to adaptively guide behavior. These findings lead to a novel
hypothesis that compulsivity results not from an imbalance in MB and MF learning systems, but rather an
alteration in their integration. The proposed K23 project will test this hypothesis for the first time. Fifty
unmedicated adults with OCD and 50 healthy controls will complete two reinforcement learning tasks while EEG
is recorded at the start and end of a 10-week period during which participants with OCD will receive a standard
course of EX/RP, the central mechanism of which is learning from prediction errors. The combination of theory-
driven computational modeling and trial-by-trial EEG analysis will be used to reveal temporally precise neural
dynamics of MB-MF integration and link this information with clinically-relevant outcomes. This K23 will provide
key training and preliminary data for a future R01 grant, launching Dr. Rapp to independence.

Public health relevance
PROJECT NARRATIVE Psychiatric disorders characterized by compulsivity, such as obsessive-compulsive disorder (OCD), result in considerable functional impairment and many individuals do not respond to gold-standard treatments. Compulsivity has long been thought to occur due to exaggerated habits and reduced goal-directed control, although more recently, this conceptualization of compulsivity as an imbalance of two cognitive systems has been challenged as overly narrow. This K23 study will leverage the measurement precision offered by theory- driven computational modeling in combination with electroencephalogram (EEG) to go beyond this binary theory of compulsivity, revealing how more complex interactions of neurocognitive subcomponents contribute to compulsivity—information that could ultimately lead to improved treatment personalization and clinical outcomes.